An ensemble deep learning model for tumor bud detection and risk stratification in colorectal carcinoma.

PROJECT ABSTRACT
Colorectal cancer (CRC) is the fourth most common cancer, and the second leading cause of cancer death in
the United States, with an estimated incidence of 151,030 new cases in 2022. According to the American Cancer
Society, the lifetime risk of developing colorectal cancer is 1 in 23 for men and 1 in 25 for women. Tumor budding
is a prognostic factor in colorectal cancer with potential to risk stratify patients and possibly guide treatment
decisions. It is defined as the presence of a single tumor cell or a cell cluster consisting of fewer than five tumor
cells at the invasive tumor front. Unfortunately, tumor budding is not routinely disclosed in pathology reports due
to lack of reproducible methods in identifying tumor buds from H&E slides. The prevalence, mortality, and risk of
colorectal cancer as well as the potential of tumor budding as a prognostic factor necessitate an accurate, easy-
to-use, reproducible system to identify tumor budding. We aim to develop a computer-aided image analysis
system to standardize the quantitative criteria used to define tumor budding from H&E slides. In addition to
identifying tumor buds, the system will correlate tumor buds with several outcomes (microsatellite instability
status, overall survival, progression free survival, and disease free survival). As part of the proposed computer-
aided image analysis system, we will first develop a sophisticated method for color deconvolution to compensate
for color variations. This will be followed by deformable image registration and deep learning modules to
differentiate tumor from non-tumor regions. The study will show that machines can be trained using deep learning
to identify different anatomical regions within H&E slides of colorectal patients. From thereon, we will rely on
scale-space theory and alpha-shapes to identify tumor buds and hotspots. We will use mathematical morphology
and differential geometry to extract visually meaningful imaging features from tumor buds and hotspots. We will
explore the potential of these imaging features along with features produced by our unsupervised multiple
instance learning in predicting outcomes. The proposed research will help identify the association of tumor
budding to colorectal cancer outcomes. The model will be subjected to rigorous statistical analysis for accuracy
and reproducibility. The project will result in innovative software tools that facilitate the selection for personalized
cancer therapies for colorectal patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because we are generating new computer-aided methods aimed at improving diagnostic quality, reducing intra- and inter-observer variability that will ultimately enable efficient patient selection for personalized cancer therapies. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to the application of novel strategies that may improve human health.